Core A - Administrative Core

Project Summary Core A, the administrative component of this Program Project, provides the organizational structure for the group. It provides support for administration of this program and facilitates interactions between the different laboratories and institutions that are involved. It is responsible for the synergy and cohesion of this program. The core is necessary in order to enhance and expedite interactions among program members and members of their laboratories. This core serves the following functions: First, it promotes cohesion of the Program Project by ensuring regular communication between the Principle Investigators. Second, it makes possible regular PI meetings, multi-lab meetings and annual retreat. Third, it provides administrative and financial support for the members so that meetings, retreats, calls and lab visits can take place. Fourth, it provides a secure web site so that data and protocols can be shared between different groups to facilitate collaborative interactions between the different laboratories and groups.

Public health relevance
Project Narrative This Program Project Grant needs the support of an administrative component, Core A, to ensure that collaborative, cooperative and informed discoveries made under the auspices of this program occur in a reliable and timely fashion. It also serves to bring together the different investigators and their groups to explore new ways of working together to contribute to understanding cancer biology with the long term goal of improving therapeutic and diagnostic outcomes.